Data Analysis Core

ABSTRACT: DATA ANALYSIS AND SUBMISSION CORE
The Vanderbilt-coordinated Human Virome Characterization Center (V2C2) is a trans-institutional initiative
aimed at an in-depth longitudinal characterization of the human virome across various biospecimen and tissue
types. Utilizing advanced genomics tools, V2C2 seeks to uncover specific viral relationships with health and
disease, thereby informing subsequent mechanistic studies. The Data Analysis and Submission Core (DASC)
will collaborate closely with the Biospecimen Analysis Core (BAC), metadata from the Biospecimen Collection
Core (BCC), and Principal Investigators to provide precise, timely, cost-effective, and integrated management,
processing, analysis, and sharing of both sequence data and related clinical metadata to reinforce reproducible,
ethical scientific discovery. As part of V2C2, the DASC aims to provide key, time-demarcated deliverables,
including: (1) Receipt and coordination of molecular data and assay conditions (from BAC) and metadata (from
the Biospecimen Collection Core); (2) Data processing and analysis, including quality control/assurance
assessment, assembly and annotation of viral genomes, microbiome profiling, and statistical analysis; (3) Data
will be shared in standard repositories (with adherence to Common Fund Data Ecosystem elements and
collaboration with Ethics, Legal, and Social Implications Core (ELSI) core to ensure ethical data-sharing practices
and deidentification). In addition to V2C2-centered duties, the DASC will undertake the following key consortium-
wide efforts: (1) participation in the analysis of cross-VCC site benchmarking studies (from a data analysis
perspective); (2) design and conduct of a pilot study that bridges the Functional Interactions awardees (under
RFA-RM-23-017) with the V2C2; (3) the establishment and leadership of data analysis working groups within
the larger HVP consortium; (4) creation of cloud-based infrastructure pipelines (harmonized across the V2C2
and other VCCs) to enable high-fidelity, reproducible host-viral analyses. The research projects within V2C2 and
other VCCs exhibit a wide range of experimental designs, encompassing a diverse array of sample types and
analytical challenges. To address these, the DASC is structured to harmonize modular bioinformatics workflows
and maintain flexibility, adapting to data from emerging technologies and methods as needed. This approach
ensures that the diverse requirements of these complex research projects are effectively met. The vision of the
DASC is to provide a collaborative structure that unites multiple investigators with experience in metagenomics,
metatranscriptomics, statistical data integration, human omics, and cloud-based computing to enable these aims
effectively.